Gut bacterial metabolism of the side-chain of corticosteroids

Project Summary
The Sterolbiome Laboratory focuses on working out host-associated bacterial steroidogenic pathways. The focus
of the parent R01 is in identifying bacterial 17α-HSDH and 17β-HSDH involved in conversion of androstenedione
to the stereoisomers epitestosterone and testosterone, respectively. So far, we have discovered a 17α-HSDH
from the gut bacterium, Clostridium scindens, and 17β-HSDH from urinary isolates of Propionimicrobium
lymphophilum. These initial discoveries led to a manuscript that is currently under review in the journal Nature.
However, we are now focusing on identifying additional isoforms of bacterial 17α-HSDH and 17β-HSDH in
human stool samples (>200 samples). To accomplish this, we will use sequence agnostic and culture
independent functional metagenomic library screening. In this approach, community DNA is partially digested
and ligated into an expression vector before transformation into E. coli. Colonies are transferred to wells of
microplates containing bacterial medium and steroid substrates. After extraction of steroid products, hundreds
to thousands of wells need to be analyzed by liquid chromatography mass spectrometry. The Sterolbiome lab at
Illinois has a much larger collection of steroids than the Metabolomics Core on campus, and even core labs at
other institutions that specialize in steroid quantification. Using core labs is both time consuming, and results in
inconsistencies as different facilities utilize different instruments, columns, and solvent systems. The throughput
we are approaching with functional metagenomic subaims makes a dedicated instrument a necessity. Since
functional metagenomics is expected to result in identification of novel enzymatic reactions, we require MS/MS
application to produce unique daughter ions which act as “fingerprints” to assist in identifying unknowns. Knowing
the mass(es) of each peak is critical to differentiating steroid ions from other compounds and provides immediate
information on likely products. Without MS/MS, we would still need to submit most samples to core labs which
is the problem to begin with. Instead, we can develop a custom standardized workflow with the ThermoFisher
Vanquish Flex UHPLC coupled with VWD & IR, and TSQ Fortis Plus electrospray ionization (ESI) Triple
Quadrupole MS. PI Ridlon has support from both his Department and College and with matching funds, the
overall cost to NIGMS for the equipment has been significantly reduced.

Public health relevance
Project Narrative Functional metagenomic screening of stool samples for novel bacterial steroidogenic enzymes necessitates a dedicated analytical instrument to allow the throughput our project requires. This instrument should be able to separate steroid isomers and determine mass and generate daughter ions that serve as “fingerprints” to assist in identification. ThermoFisher Vanquish Flex UHPLC coupled with VWD & IR, and TSQ Fortis Plus electrospray ionization (ESI) Triple Quadrupole MS will provide the platform we need to complete the parent project.